“Pharmacologic targeting of NR4A1 and NR4A2 to activate glioblastoma treatment response”

Resistance to standard of care (SOC) temozolomide (TMZ) and radiation treatment (XRT) limits survival of the
most common adult brain cancer, glioblastoma (GBM), to 12-18 months. Despite promising results in other
cancers, robust immunosuppression in GBM has also limited the responses to immune checkpoint inhibitors
(ICIs). Reciprocal interactions in the GBM tumor microenvironment (TME) between mesenchymal changes and
immunosuppression enhance resistance to chemoradiation and immunotherapy, respectively. Therefore, a
compelling therapeutic strategy for GBM is to concurrently reprogram the mesenchymal and immune
suppressive TMEs and potentiate ICI and SOC therapy. The NR4A1 and NR4A2 orphan nuclear receptors are
compelling targets to achieve this goal. We synthesized a series of novel bis-indole–derived ligands (CDIMs)
with potent dual antagonism of NR4A1 and NR4A2 and negligible in vivo toxicity, of which six demonstrated nM
range KDs for both receptors. Genetic based NR4A 1 and 2 loss of function strongly activates anti-cancer
immune responses by reversing T-cell exhaustion which underlies poor ICI responses in GBM. In addition,
NR4A1/2 promote EMT in other cancers which contributes to chemoradiation resistance. Finally, high levels of
NR4A1/2 expression in GBM are strongly associated with decreased patient survival after conventional
treatments. Therefore, we propose to test the hypothesis that CDIM inhibition of NR4A1/2 reprograms the
GBM TME and potentiates ICI and TMZ/XRT responses. Further NR4A1/2 upregulates PD-L1 and TWISt1,
key regulators of GBM immune suppression and mesenchymal phenotypes, respectively. Preliminary studies
demonstrated that CDIMs inhibit PD-L1 and TWIST1 expression, reverse immune suppressive myeloid and T
cell phenotypes and prolong survival of experimental GBMs. We will test our hypothesis by i) identifying lead
dual NR4A1/2 CDIM compounds based on inhibition of malignant and mesenchymal GBM cell properties
(proliferation, self-renewal, invasion) and reversal of dysfunctional T cell phenotypes in vivo (Aim 1), ii)
establishing the functional impact of NR4A1/2 CDIMs to reprogram the immune suppressive and mesenchymal
TME (Aim 2) and iii) quantifying the effects of NR4A1/2 CDIMs to potentiate ICI and SOC responses in mouse
GBM syngeneic models and define the role of PD-L1 and TWIST1 in their mechanisms of action (Aim 3).
Quantification of potency, pharmacokinetics and preclinical anti-tumor activity alone and in combination with to
standard of care TMZ-XRT and ICIs is expected to identify candidate CDIMs for consideration in future clinical
trials. Through application of powerful bioinformatic tools that model the cancer TME through integration of
scRNAseq, cyTOF and IMC data, these studies are expected to shed new light on novel mechanisms by which
mesenchymal and immune suppressive TMEs interact to coordinately drive treatment resistance in GBM through
NR4A1/2. To achieve our goals, we assembled a unique multidisciplinary team with expertise in medicinal
chemistry, neuro-oncology, GBM biology and preclinical modeling, and immuno-oncology.

Public health relevance
Resistance to conventional chemo-radiation and immunotherapy in glioblastoma (GBM) results in uniform lethality by 12-18 months in the majority of patients. Here we propose to demonstrate novel therapeutic potential of drugs termed CDIMs that target NR4A1 and NR4A2 nuclear orphan receptors which drive interacting mesenchymal and immune suppressive tumor microenvironments that promote resistance to standard chemo- radiation and immune checkpoint therapy, respectively. By disrupting NR4A1/2 effects on the tumor microenvironment, CDIMs are expected to have robust anti-tumor activity and potentiate current chemo-radiation or immune based therapies in GBM.